TRANSMISSION ELECTRON MICROSCOPE

A state-of-the-art multipurpose electron microscope is being sought for shared use, primarily by three major user groups with active ongoing biomedical research programs of strong multi- and interdisciplinary content. The instrument will be capable of operation in high resolution transmission mode, ease of use for efficient obtaining of large numbers of in-focus micrographs, routine use of goniometer for stereoscopy, availability of a cryo-system and option of attachments or modification for future modernization of the same instrument. The instrument will also be used in conjunction with a highly productive training program oriented around the specific aims of the user's (funded) research projects. It will substantially benefit present and future activities by providing an instrument that is unavailable or to which availability is highly limited. The studies of the major users are clearly interrelated with distinct areas of overlap and represent a main inter-disciplinary approach to studies in neurobiology. The instrument will not only contribute to these correlative studies of brains but will provide a facility for collaborators and other potential users in the same area, extending the research capabilities of the overall research community at this institution.